PhD Training Program in Virology and Gene Therapy

Project Summary
Unifying scientific principles in the life sciences continue to be discovered in viral systems. Gene therapy and
oncolytic virotherapy depend on viral vectors. Awareness that a deep understanding of fundamental virology is
necessary for the development of gene therapy led to the foundation of the Virology and Gene Therapy (VGT)
track of Mayo Clinic Graduate School of Biomedical Sciences (MCGSBS) in 2004; since 2018 the NIH supports
three of its best pre-doctoral students. Ph.D. training leverages the strength of basic research and the robust
translational infrastructure at Mayo Clinic. Training is performed in the laboratories of 22 VGT faculty members.
Eight are from the Department of Molecular Medicine, three from Medical Oncology, two each from Infectious
Diseases, Hematology, and Biochemistry/Molecular Biology. The others are from five different departments. The
faculty is united by leadership in research on viruses, vectors, mechanisms of human disease, cancer treatment,
and gene therapy. VGT popularity is based in part on its unique training opportunities in both virology and the
translation of viral and gene therapeutics. During the entire time of their thesis the students engage in a full array
of programmatic activities including journal clubs, seminar series, an annual retreat and national scientific
meetings. Requirements for the VGT track conform to the general requirements of MCGSBS. Continued NIH
support of three trainees would allow further development of this successful and innovative program.

Public health relevance
Project Narrative Viruses continue to shape human history through disease, but modified viruses are used as vaccines. The study of viruses has become a source of knowledge: unifying scientific principles are discovered through virology. The Virology and Gene Therapy track forms trainees into rigorous scientists and innovators who further develop the science of virology while also leveraging it to prevent and treat cancer and genetic diseases.